Regulatory Pathways in Osteoclasts and Immune Cells during Inflammatory Arthritis

DESCRIPTION (provided by applicant): During Rheumatoid Arthritis (RA), increased immune cell activation leads to focal bone erosion as well as systemic bone loss, both mediated by osteoclasts (OCs). Dendritic cells (DCs) are critical components of the inflammatory response associated with RA as they are responsible for the activation of T lymphocytes, due to abnormal presentation of self-antigens. Neutrophils can further enhance the inflammatory condition by recruiting more DCs and contribute to local bone erosion by actively secreting inflammatory and pro-osteoclastogenic cytokines. Unfortunately, traditional pharmacotherapy to block the activity of inflammatory cytokines can be inadequate in controlling symptoms and disease progression. Our overall goal is to identify signaling molecules that are critical to modulate the inflammatory and osteolytic components of RA and that may lay the groundwork for novel and more effective therapeutic approaches. We have previously found that PLCγ2 is a critical modulator of bone homeostasis and inflammatory responses associated with RA. However, PLCγ2 shares high homology with the more ubiquitously expressed PLCγ1, thus rendering its specific targeting difficult. Diacylglycerol (DAG) is a downstream product of PLCγ2 catalytic activity and data from our group and others indicate that it mediates PLCγ2 function in OCs and immune cells. In order to study the role of DAG, we now turned our attention to DGKζ, an enzyme that decreases cellular levels of DAG by converting it to phosphatidic acid (PA). Thus, DGKζ-deficiency causes accumulation of DAG. Our preliminary data indicate that DGKζ is highly expressed in OCs, neutrophils and DCs. We also found that mice lacking DGKζ have a substantial osteoporotic phenotype, characterized by reduced trabecular number and thickness and enhanced OC formation and function. Thus, our data indicate that DGKζ is a negative modulator of osteoclast activation. Based on this information, our central hypothesis is that DGKζ, via modulation of DAG, is a common regulator of bone and immune cells downstream of PLCγ2. Thus, we propose to: Specific Aim 1: Investigate the mechanism by which DGKζ modulates osteoclast formation and bone resorption in vitro and in vivo. Specific Aim 2: Examine the role of DGKζ in development and resolution of serum induced arthritis and its effect on neutrophil activation. Specific Aim 3: Determine the role of DGKζ in antigen-induced arthritis and its effect in DC- mediated T cell activation. The goal of this application is to demonstrate the importance of DGKζ in the activation and functionality of OCs, neutrophils and DCs as a way to target both the osteolytic and inflammatory components of RA. This novel approach might lay the basis for new therapeutic interventions for RA. PUBLIC HEALTH RELEVANCE: Considering the impact of inflammatory arthritis and associated bone loss in the western population, the significance of our study consists in having identified DGK6 as a novel regulator of bone homeostasis. The goal of this application is to demonstrate the importance of DGK6 in the activation and functionality of OCs, neutrophils and DCs as a way to target both the osteolytic and inflammatory components of Rheumatoid Arthritis. This novel approach might lay the basis for new therapeutic interventions for Rheumatoid Arthritis and inflammatory bone loss.

Public health relevance
Project Narrative: Considering the impact of inflammatory arthritis and associated bone loss in the western population, the significance of our study consists in having identified DGKζ as a novel regulator of bone homeostasis. The goal of this application is to demonstrate the importance of DGKζ in the activation and functionality of OCs, neutrophils and DCs as a way to target both the osteolytic and inflammatory components of Rheumatoid Arthritis. This novel approach might lay the basis for new therapeutic interventions for Rheumatoid Arthritis and inflammatory bone loss.